Childhood Cancer Data Initiative (CCDI)

The Childhood Cancer Data Initiative (CCDI) focuses on the critical need to collect, analyze, and share data to address the burden of cancer in children, adolescents, and young adults (AYAs). The initiative supports maximizing the use and benefit of data from childhood and AYA cancer research for patients and survivors and aims to make it easier for researchers to learn from each of the approximately 16,000 children and adolescents diagnosed with cancer in the United States each year. - (10/5/2020 Source: https://www.cancer.gov/research/areas/childhood/childhood-cancer-data-initiative)